Applications of Biocatalytic C–H Functionalization in Complex Molecule Synthesis

Project Summary
Despite remarkable advances in the past decade, contemporary chemical methods for C–H oxidation and C–H
functionalization still face significant challenges in achieving useful levels of selectivity on complex scaffolds.
While the oxidative enzymes that have evolved to perform these transformations in Nature are capable of
addressing these selectivity issues, their applications in complex molecule synthesis have been relatively limited.
Seeking to bridge this gap, our lab has developed new biocatalytic C–H functionalization tools and investigated
their applications in the chemoenzymatic syntheses of bioactive natural products. These tools are obtained from
initial biosynthetic studies on secondary metabolites, which to date have identified a suite of unique and
synthetically-useful enzymes to address unsolved C–H functionalization problems in organic chemistry. In turn,
these discoveries serve as useful starting points for further activity optimization through enzyme engineering and
for chemoenzymatic strategy development. Our chemoenzymatic syntheses are concise, step efficient and
readily amenable to scale, demonstrating their strategic advantages. Furthermore, our achievements in the last
funding period demonstrate that this strategy can be readily adapted for rapid analog generation to enable
subsequent mode of action identification and structure-activity relationship studies. The current proposal outlines
our long-term research program in the area of biocatalytic C–H functionalization with specific applications in
natural product synthesis. Projects proposed within the program include the development of chemoenzymatic
strategy to synthesize bioactive alkaloids and macrolides and explore their structure-activity relationships, the
development of new biocatalytic C–H functionalization methods beyond hydroxylation and the development of a
family-wide activity profiling for reaction with challenging substrates. Significant elements of innovation in this
work include (1) the discovery, functional annotation and biocatalytic exploration of previously uncharacterized
enzymes from various biosynthetic pathways, (2) the formulation of new chemoenzymatic strategies to access
precious bioactive compounds with unsurpassed levels of efficiency, and (3) the generation of novel structural
analogs for collaborative medicinal chemistry optimization and structure-activity relationship studies. More
generally, the proposed work will further stimulate the development of new logic in chemical synthesis centered
on the use of Nature's biocatalytic repertoire, radically altering the way chemists approach synthetic planning
and allowing new small molecules to be prepared in a more efficient and practical manner.

Public health relevance
Project Narrative/Public Health Relevance The ability to repurpose biological systems for applications in chemical synthesis has broad-ranging impacts on multiple research areas in biomedical science, including medicinal chemistry, drug discovery and green biotechnology development. Enzymatic C–H functionalization, when strategically used, will allow efficient access to new chemical space previously unattainable using contemporary technology, thereby enriching the pool of available small molecules for drug discovery campaigns. By pursuing specific applications on natural product scaffolds with promising bioactivities, our work will provide significant contributions towards the advancement of novel therapeutic candidates and understanding of their modes of action.